Longitudinal Networks Core

PROJECT SUMMARY/ABSTRACT (LONGITUDINAL NETWORKS CORE)
The long-term goal of the Longitudinal Networks Core (LNC) is to serve as a sustainable resource for the Rural
Drug Addiction Research (RDAR) Center, the University of Nebraska, and other academic researchers to inves-
tigate substance use/misuse and to address the etiology, assessment, prevention, and treatment of this critical
public health challenge. The LNC was designed to meet a pressing need for cost-effective access to long-term
recruitment and retention services capable of maintaining a study cohort and to provide expertise in community-
engaged approaches and network designs. In Phase 1, the LNC supported researchers from a wide range of
disciplines and created the critical infrastructure for managing projects, data, and software use. The goal of the
LNC in Phase 2 will be to maintain and extend: 1) access to a longitudinal cohort of people who use drugs from
which to recruit study participants; 2) data describing factors affecting regional patterns of substance use; 3) use
of LNC software to collect responsive fine-grained data from participants; 4) support for network sampling or
analytic approaches; and 5) consultation in community-engaged research, field-based biospecimen testing, ep-
idemiological data collection, respondent driven sampling, intervention design, and research with hard-to-reach
populations. By offering resources and expertise that do not otherwise exist in the region and would be prohibi-
tively expensive for early-stage investigators, the LNC will achieve its vision of increasing substance use/misuse
research by elevating research capacity throughout Nebraska. The RDAR Center’s strong collaborations with
university-wide research centers, campuses across the University of Nebraska system, and statewide and na-
tional IDeA-program partners will be leveraged to expand services and the user base in Phase 2. Towards this
end, the LNC will establish, maintain, and expand the Core’s active regional longitudinal cohort of people who
use drugs (Aim 1). In doing so, the LNC will provide researchers access to a Participant Pool for recruitment
into affiliated projects such as context-sensitive samples for biological and epidemiological research and inter-
vention trials and secondary data for novel network approaches to understanding regional patterns of substance
use. The LNC will also expand the user base of LNC services (Aim 2) by leveraging the Phase 1 success of
software platforms developed by the LNC to enable innovative research in community settings. LNC services
will facilitate the transition of early-stage investigators to independence, the development of interdisciplinary
teams, and the successful pursuit of large external funding within RDAR’s thematic focus. These endeavors, in
turn, will grow an already impressive concentration of expertise for substance use and related health disparities
research and cultivate collaborations nationally through existing IDeA-state partners and connections. These
efforts will position the LNC for independence and sustainability and as a national leader, contributing a unique
regional, rural, and research focus to NIH’s Center of Biomedical Research Excellence portfolio.